Overcoming complications of polypropylene prolapse meshes: Development of novel elastomeric membranes

PROJECT SUMMARY
Pelvic organ prolapse (POP) is a common, costly condition in women with a lifetime risk of surgical repair of
12.6%. Of those undergoing a native tissue repair, 70% will fail by 5 years prompting surgeons to turn to
biomaterials, most commonly polypropylene mesh (PPM). Unfortunately, POP meshes were never designed
specifically for the vagina and are hampered by complications. Our studies show that implantation of PPM leads
to degeneration, atrophy, and loss of function of the vagina. The high material stiffness of polypropylene dictates
that meshes manufactured from this polymer are knitted, leading to a device that undergoes pore collapse,
wrinkling, and permanent deformation upon tensioning. These changes result in an increased mesh burden, a
heightened foreign body response, and poor outcomes. To overcome the limitations of current PPMs, we have
manufactured an elastomeric membrane (EM) from polycarbonate urethane (PCU) for use in POP repair
surgeries. The EMs are 3D printed (to afford rapid prototyping) with a material stiffness that is on the same order
of magnitude as that of the vagina, a geometry that favors stable pores, and minimal wrinkling with tensioning.
In vivo assessment of physicochemical properties of small EM constructs (2x1cm2) demonstrated a markedly
improved host response as compared to similarly sized PPMs. In this renewal application, we propose to expand
our in vivo evaluation to full length EMs in a nonhuman primate POP repair model (sacrocolpopexy) and to
improve our product based on potential limitations. First, softer devices, while better for host response, can lead
to surgical failure under lower loads, necessitating thicker devices or devices that are spatially graded to provide
increased mechanical support in certain locations such as mesh anchor points. Second, our current EMs do not
bioactively interact with the vagina which is compromised in individuals with POP. To address these issues, we
propose to develop the next generation of mechanically graded and functionally interactive EMs,
hypothesizing they will improve long-term tissue viability and reduce the host response to the implanted
device. We test this hypothesis in 3 aims. In Aim 1, we develop tunable membranes that are mechanically
graded with less material over the vagina and increased material in stem that forms a bridge to the sacrum. This
design feature will decrease risk of failure at the sacrum and in the bridge and facilitate tacking or sewing into
the device without negatively impacting the vaginal host response. In Aim 2, we take advantage of our expertise
in polymer synthesis to develop an EM that is functionalized with synthetic peptides designed to promote
interaction/integration into the host extracellular matrix and to overcome some of the negative impacts of
biomaterials on host tissues. In both Aims 1 and 2, we evaluate the host response in vivo to the small EM
constructs using a rabbit vaginal implantation model. In Aim 3, we implant the final iterations of the EM
prototypes developed in this and our previous application in a nonhuman primate prolapse repair model for a
final preclinical assessment. We look forward to this opportunity to improve outcomes for women with POP.

Public health relevance
PROJECT NARRATIVE By age 80, 12.6% of women in the United States will have a surgery to repair pelvic organ prolapse (POP). Current POP repairs are performed using polypropylene hernia meshes rebranded for prolapse surgery, which has led to complications. Here we finalize the design of a novel device fabricated specifically for the vagina that has high potential to markedly improve the outcomes of prolapse surgeries while minimizing complications.